Complementary and Integrative Health Stepped Care for Co-occurring Chronic Pain and PTSD

Project Summary/Abstract
My application for a Pathway to Independence Award represents the ideal next step toward reaching my goal of
becoming a leading independent investigator focused on the development and evaluation of systems-based
approaches for effectively delivering CIH interventions for common chronic conditions. The current application
proposes the development and pragmatic pilot testing of a novel CIH-based stepped care approach for co-
occurring chronic pain and PTSD. The aims of the proposal strategically align with my specific career
development goals of gaining expertise in 1) systems-based care models for complex co-occurring physical and
mental health conditions, 2) pragmatic clinical trial design for CIH interventions, and 3) user-centered design
strategies for learning health systems. Also included is a professional development goal to 4) ensure my
readiness to transition into an independent researcher and faculty member at the rank of Assistant Professor. In
addition, the training plan includes 2 goals in the R00 phase of the award: 5) successfully transition into an
Assistant Professor position and maintain a successful independent research program; and, 6) conduct a pilot
randomized effectiveness trial and use pilot data to write and submit a competitive R01-level grant to NCCIH.
The training plan includes an excellent research mentorship team with an established history of consistent
independent federal funding and mentorship to ensure that these 6 goals are met. Dr. Steve Zeliadt (Primary
Mentor) is an expert in pragmatic trial design, dissemination and implementation science, and quantitative data
analysis; Dr. Kurt Kroenke (Co-Mentor) is an expert in systems-based and stepped care models within primary
care settings for patients with chronic physical and mental health conditions; and Dr. Rhonda Williams (Co-
Mentor) is an expert in pragmatic clinical trial design for CIH interventions and the development, treatment, and
theoretical underpinnings of CIH interventions for individuals with complex symptom presentations. In Aim 1, we
will use patient semi-structured interviews and clinic focus groups to identify provider strategies and patient
perspectives relevant to treating co-occurring chronic pain and PTSD in a primary care clinic. Using proven
stepped care approaches developed by mentor Dr. Kroenke for pain and by consultant Dr. Zatzick for PTSD as
the foundation, our team will develop a CIH-based stepped care approach for co-occurring chronic pain and
PTSD in primary care guided by current evidence of CIH interventions while including patient, provider, and clinic
input. In Aim 2, we will iteratively refine the protoype using user-centered design strategies. In Aim 3, we will
conduct a pragmatic pilot trial of our CIH-based stepped care approach v. treatment as usual in two primary care
settings (one rural, one urban). The experiential components of each aim, combined with my mentorship plan,
will ensure my readiness for independence as an expert in the development and evaluation of systems-based
approaches for effectively delivering CIH interventions. The training goals and research aims align with the
important NCCIH priorities of CIH interventions for co-occurring chronic pain and PTSD and well-being.

Public health relevance
Project Narrative The current proposal is designed to position the candidate to be a leading independent investigator focused on the development and evaluation of systems-based approaches for effectively delivering complementary and integrative health (CIH) interventions (e.g., non-pharmacologic mind-body interventions such as mindfulness meditation) for common chronic conditions. The proposal focuses on chronic pain and co-occurring posttraumatic stress disorder (PTSD), a population of patients who often seek treatment in primary care, where effective CIH interventions may not be available due to limited resources or patient access (e.g., community care in rural settings). The current proposal utilizes user-centered design strategies to incorporate CIH interventions into proven stepped care approaches designed for primary care settings, and then pragmatically tests the novel approach.